Support Services for the CTEP Pharmaceutical Management Branch (PMB)

The Pharmaceutical Management Branch (PMB), Cancer Therapy Evaluation Program (CTEP), Division of Cancer
Treatment and Diagnosis (DCTD), National Cancer Institute (NCI) is responsible for the management and distribution
of agents used in the majority of NCI sponsored treatment trials, as well as agent distribution support for select
Division of Cancer Prevention (DCP) and non-NCI sponsored treatment trials. The purpose of this contract is to
provide support of PMB functions, mainly in support of drug distribution (e.g., all processes surrounding agent
management – order processing, transfers, local destruction, investigator brochure distribution, stock recovery notice
distribution, etc.), investigator/associate registration processing and maintenance, curation of database containing
NCI list of organizations associated with NCI trials, as well as helpdesks for managing the investigator, associate and
organizations databases.